Effects of Experimental Sleep Restriction in Offspring of Hypertensive Parents

PROJECT SUMMARY
Hypertension is the chief risk factor for cardiovascular (CV) disease and a major threat to population health.
Given the burden of hypertension, it is critical to identify risk enhancers in populations susceptible to CV
disease, for risk stratification. While family history of hypertension, especially parental hypertension, is well-
known as a robust predictor of high blood pressure (BP) and CV disease in the offspring, the role of chronic
sleep deficiency is being increasingly recognized. Evidence from epidemiological and laboratory-based
studies converges to indicate that insufficient sleep increases BP and alters CV disease mechanisms, thus
predisposing to adverse outcomes. Whether the detrimental impact of insufficient sleep on CV risk is
potentiated in populations with preexisting vulnerabilities, such as the offspring of hypertensive families, is
plausible yet unknown. To bridge this gap, we propose a randomized, controlled, crossover, 10-day
inpatient study to investigate whether experimental sleep restriction increases BP and impairs CV function
in individuals with a positive parental history of hypertension (+PHH), and whether the hypothesized
adverse impact of shortened sleep is greater in this group compared to individuals with a negative PHH
(−PHH). We propose the following Specific Aims comparing sleep restriction to normal sleep in the
offspring of hypertensive parents relative to the offspring of normotensive parents.
Aim 1. To compare the effects of sleep restriction on ambulatory BP in individuals with a +PHH compared
to those with a −PHH.
Aim 2. To determine the impact of sleep restriction on neural circulatory control and vascular function in
individuals with a +PHH compared to those with a −PHH.
Aim 3. To explore epigenetic and transcriptomic modifications in response to sleep restriction in individuals
with a +PHH compared to those with a −PHH.
This proposal builds upon important strengths, including an interdisciplinary team of investigators with
unique experience and expertise; supporting preliminary data; a robust study design which will ensure
rigorous and unbiased research; and integration of physiological, behavioral, and omics variables in a
translational framework. This mechanistic study will inform on the role of sleep deficiency as a CV risk
enhancer in individuals with familial predisposition to hypertension, and guide future preventative strategies
targeting sleep to ameliorate CV risk in vulnerable populations.

Public health relevance
PROJECT NARRATIVE Insufficient sleep is a strong cardiovascular risk factor and its negative impact may be exacerbated in populations predisposed to cardiovascular disease, such as the offspring of hypertensive families. We will investigate whether experimental sleep restriction increases blood pressure and impairs cardiovascular function in individuals with a parental history of hypertension, and whether the hypothesized adverse impact of shortened sleep is greater in this group compared to individuals without a parental history of hypertension. This study will inform on the role of sleep deficiency in deteriorating the cardiovascular profile of those with a familial predisposition to hypertension, and guide future preventative strategies targeting sleep to reduce cardiovascular risk in vulnerable populations.